Proteomics Core

Proteomics Core – Abstract
The DDRCC Proteomics Core will provide DDRCC Members with cutting edge mass spectrometry resources to
support the Center’s thematic areas. During the previous funding period, the Core delivered outstanding
services, with extremely high user satisfaction and supported a multitude of manuscripts and grant applications.
The DDRCC Proteomics Core is housed within the larger MUSC Proteomics Center and is equipped with state-
of-the-art instrumentation and overseen by experts in LC-MS/MS-based proteomics and MALDI mass
spectrometry imaging (MSI). The Core provides LC-MS/MS based proteomic methods to interrogate the impact
of disease, drugs, and nutrient status on protein abundance, protein interactions and post-translational
modifications. DDRCC Members are assisted with customized, project- and modification-specific method
development. The Core is one of a handful of facilities throughout the world that provides novel MSI capabilities
to spatially resolve metabolites, lipids, glycolipids, glycans, proteins and extracellular matrix proteins in normal
and diseased tissues. These capabilities have recently expanded to enable screening for analytes of interest
present on captured proteins and cells. DDRCC Members have access to new technologies as they are
developed. Drs. Drake, Ball, and Angel lead the Core’s efforts in glycan imaging, LC-MS/MS-based proteomics,
and single cell and extracellular imaging, respectively. The aims of the Core are as follows: Aim 1) To provide
highly sensitive and reproducible LC-MS/MS-based proteomic methodology; 2) To provide and to continue to
develop individualized multiplexed spatial approaches to measure proteins, lipids, and post translational
modifications within a single tissue section; 3) To provide and to continue to develop an individualized multimodal
single cell spatial omics resource focused on single cell imaging combined with spatial glycomics and spatial
matrisomics. Based on polling of the DDRCC Members, we expect this core to continue to be highly utilized.